IGF::OT::IGF JIANG, JIMING: Variance and interval estimators of age-adjusted rates with sampling errors in the denominators

Variance and interval estimators of age-adjusted rates with sampling errors in the denominators